Admin Core

PROJECT SUMMARY ADMINISTRATIVE CORE
The Administrative (Admin) Core will provide the infrastructure to support all communication, coordination,
oversight and management functions of the proposed Centers of Research Translation (CORT) P50. The Admin
Core will be led by PD/PIs Virginia Pascual, PhD, and Duygu Ucar, PhD, with program management support
from an experienced Program Administrator; and external advisory support from an External Advisory
Committee (EAC). The Admin Core will contribute to program success by: 1) facilitating communication,
organizing meetings, and fostering a strong collaborative environment among the PIs/Investigators; 2)
providing oversight and monitoring of progress of the Projects and Core towards their specific milestones; 3)
optimizing resource allocation and fiscal management; 4) seeking guidance from the EAC and NIH program
officials, implementing their recommendations, and generating progress reports; 5) Arranging an annual EAC
meeting and Lupus Symposium; 6) Oversee issues related to intellectual property and regulatory issues
surrounding research using human subjects; 7) ensuring rigorous data and sample management and efficient
data and resource sharing. These activities will be executed within five main areas of focus: (a) Leadership; (b)
Management; (c) Communication; (d) Pilot & Feasibility Programs; and (e) Enrichment Programs. Through these
activities, the Admin Core will provide the critical infrastructure necessary to ensure the proposed multi-site, and
multi-project program achieves its component and collective goals, yields results of lasting and (inter)national
impact, and positively benefits the patient population under study as well as the general public.